MAb Passive Vaccination against Acinetobacter baumannii

PROJECT SUMMARY/ABSTRACT
In contrast to other resistant bacteria, virtually no antibiotics are in the pipeline to deal with XDR A. baumannii.
There is a critical need for new strategies to prevent and treat these infections. We spent the first grant period
raising MAbs to A. baumannii capsule, and have now identified 4 anti-capsular MAbs (2 of which were used to
generate a bi-specific MAb, leaving us with 3 MAb molecules) that collectively bind to 80-90% of US clinical
isolates and protect mice from lethal infection. These 3 lead candidates are all highly potent, achieving 100%
protection in bacteremia models at single doses of ≤ 50 µg. They are also protective in pneumonia models of
infection, and synergize with antibacterials. Furthermore, the bi-specific MAb has increased potency compared
to each of its individual MAbs, and retains binding for all target strains, and efficacy in vivo. This lead three-
MAb therapeutic has begun translation into full GMP and toxicity, planning for a future Phase I clinical trial.
Our goals for the renewal are to enhance feasibility of clinical development and deployment of the
MAbs by closing any coverage gaps against international strains, defining surrogate efficacy markers, and
validating key assays to support clinical trials and future clinical deployment. We have obtained a new global
strain collection, and entered into key partnerships to further these aims, including experts at multi-valent MAb
synthesis, clinical microbiology laboratory operations, and statistics. Our Aims are to:
Specific Aim 1: Define and optimize strain coverage and surrogate efficacy markers for international
clinical strains of A. baumannii. We have collected 50 strains each from Taiwan, Southeast Asia, China,
Europe, and South America. We will survey our 3 MAbs against all acquired strains, assessing flow binding
and macrophage uptake, and will assess efficacy in our IV bacteremia model for representative strains. We
will raise news MAbs as needed to close international strain coverage gaps.
Specific Aim 2: Validate bioassays to enable clinical trials of the MAbs, including potency and human
surrogate efficacy markers. We will validate LC-MS/MS for the specific amino acid sequences of our
variable regions to quantify our MAbs when spiked into human blood, distinct from background antibodies. We
will adapt our well-established HL-60 assays to quantify opsonic activity of MAb in human plasma. Finally, we
will use multiplex Luminex assays to quantify cytokine modulation of fresh human leukocytes.
Specific Aim 3: Optimize a rapid in vitro binding assay as a “susceptibility testing”-equivalent to
support clinical trials and deployment of the MAbs. We will validate rapid, high throughput flow binding
assays to correlate with protection in mice as a “susceptibility-test equivalent”.
Novel solutions for A. baumannii infections are a critical unmet need. We have developed a promising MAb
regimen that improves outcomes during blood and lung infection in mice. We will define global strain
coverage, close any identified gaps, and develop bioassays to support clinical testing of the MAbs.

Public health relevance
Project Narrative Acinetobacter baumannii is one of the few types of bacteria that has become resistant to every antibiotic available. New treatments are desperately needed, since the death rate from these infections that are resistant to all antibiotics is high, and no new antibiotics that can kill A. baumannii are in development. The purpose of the current grant is to use the immune system to treat these infections using a vaccine made up of special proteins called antibodies.